Clinician Scholar Career Development Program (CSCDP)

Project Summary
The Clinician Scholar Career Development Program (CSCDP) is an annual two-day training workshop for
orthopaedic residents in their PGY2-PGY5 years, surgeons in fellowships, and junior faculty (through year
three) who have the potential and desire to become orthopaedic clinician scholars. Clinician scholars advance
the field of orthopaedics through innovative research and peer-reviewed funding. The CSCDP seeks the best
and the brightest; CSCDP participants are selected via a highly competitive application process. The program
was created in 2003 as the Clinician Scientist Development Program to address a growing concern over the
steady decline of orthopaedic clinician researchers and to confront the lack of basic and clinical research in
many residency programs. The CSCDP has been a partnership between the American Academy of
Orthopaedic Surgeons (AAOS), the Orthopaedic Research Society (ORS), and the Orthopaedic Research and
Education Foundation (OREF) since its inception, and has expanded over the years to include more
participants and cover a wide array of issues spanning the career timeline of a clinician scholar. General
session topics include “Beginning Your Career as a Clinician Scientist (Scholar)”; “Orthopaedic Research:
Bench or Bedside?”; “Building Blocks for a Successful Clinician Scientist Career”; “Challenges and Successes:
Personal Experiences from CSCDP Graduates”; “Work-Life Balance”; “Research Collaboration”; and
“Resources and Opportunities for Research Funding”. Program participants seek to enhance the competencies
needed for success as both a surgeon and a scientist: scientific knowledge, professionalism, responsible
conduct of research, research skill development, management and leadership skills, and communication skills.
The CSCDP has a proven track record of success and offers world-class scientific faculty mentors, including
department chairs, NIH R01 and other grant recipients, and highly published authors. The two-day program
includes didactic lectures, interactive small group breakout discussions, networking meals, and interactive
panel discussions with faculty. Participants in the program gain insight into pathways to success in a scholarly
career through departmental support, protected research time, collaboration, funding resources, and work-life
balance. They learn to maximize efficiency based on individual career priorities and increased awareness of
grant funding opportunities. By the end of the program, participants are able to create 5- and 10-year plans for
their career development with concrete clinical and research goals.

Public health relevance
Project Narrative Orthopaedic clinician scholars generate significant contributions to the field of orthopaedics. Unfortunately, due to a variety of factors in the healthcare environment, the number of surgeon-scientists has been on the decline in recent years. The Clinician Scholar Career Development Program offers the orthopaedic profession a new source of clinician scientists engaged in research that advances orthopaedic surgery and musculoskeletal medicine.